Interactions between Mitochondria, ER, and Amyloid

Project Summary and Abstract
Alzheimer’s disease (AD) is the most common form of dementia diagnosed through the presence of tau
tangles and amyloid beta (Aβ) plaques within the brain. Aβ is generated from amyloid precursor protein (APP),
an integral membrane protein. APP and Aβ localize to mitochondria and mitochondrial associated membranes
(MAMs). MAMs are endoplasmic reticulum (ER)-mitochondria contact sites and are associated with altered
function of both the ER and mitochondria. Previous studies have shown that MAM activity directly influences
APP processing into Aβ. We hypothesize that localization of APP at mitochondria and MAMs dictates Aβ
production.
Prior studies indicate APP localization at the mitochondria, ER, and MAMs affects their function, but an
overall mechanism is not understood. Mitochondrial and ER dysfunction are observed in AD. Impaired
mitochondrial bioenergetics, increased oxidative stress, and altered mitochondrial calcium, cholesterol, and
phospholipid metabolism are evident in models of AD. MAMs are known to modulate these functional
modalities between mitochondria and ER, and upregulation of MAMs is observed in AD. This upregulation of
MAM function is hypothesized to drive APP processing into Aβ and disrupt mitochondrial and ER function.
We will test our hypothesis in two aims. We will elucidate the effects of APP localization on Aβ
production and evaluate if MAM function influences localization of APP. We will address how APP and Aβ
production interact with MAM function. We will also evaluate AD and cell-type specific changes between these
relationships. Addressing the relationship between MAMs, APP, and Aβ production will provide novel insights
into their roles in AD pathology.
This F31 award is designed to further Taylor Strope’s career path by complimenting her current training
and developing expertise in new areas. These new areas include genome editing and differentiation of induced
pluripotent stem cells (iPSCs), mitochondrial/ER biology, and APP biology. At the University of Kansas Medical
Center (KUMC), Taylor Strope will work with her mentors, Drs. Wilkins and Swerdlow of the Alzheimer’s
Disease Research Center. The expert mentoring team, strong training environment, and research experience
are imperative for advancing Taylor Strope’s academic career goals.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the most common form of dementia diagnosed through the presence of brain amyloid beta (Aβ) plaques, generated from amyloid precursor protein (APP). APP and Aβ localize to mitochondria and mitochondrial associated membranes (MAMs). We will test the hypothesis that the cellular localization of APP at mitochondria and MAMs dictates Aβ production.